Buprenorphine analogs for the treatment of opioid abuse

PROJECT SUMMARY
The recent marked increase in misuse and abuse of opioids and the epidemic of opioid overdose mortality
have greatly affected our society. Given that non-human primate models offer the most phylogenetically
appropriate evaluation of opioid receptor functions and drug effects, the goal of this proposal is to establish a
translational bridge for the functional profiles of buprenorphine analogs to ameliorate opioid-assoicated side
effects in primates. Previous studies demonstrate that a buprenorphine analog BU08028 with mixed mu opioid
peptide (MOP) and nociceptin/orphanin FQ peptide (NOP) partial agonist activities is a safe analgesic without
abuse liablity. The proposal will further investigate the funcitional profiles of buprenorphine-inspired
compounds, BU08028 and BU14003, in modulating three major aspects of opioid use disorder, i.e., abuse
liability, relapse, and physical dependence. The proposal contains three aims: 1) To distinguish the functional
profiles of buprenorphine-inspired compounds from opioids following acute and chronic administration. 2) To
demonstrate the functional effectiveness of buprenorphine-inspired compounds to attenuate the abuse-related
effects of opioids including oxycodone and heroin. 3) To demonstrate the functional effectiveness of
buprenorphine-inspired compounds to alleviate the adverse effects from opioid dependence. These non-
human primate behavioral assays have been designed specifically to reflect the therapeutic potential of
buprenorphine-inspired compounds for inhibiting opioid-assoicated abuse liability and physical dependence
and assess its functional effecitvenss and selectivity. Our unique set of behavioral and physiological assays in
awake, behaving non-human primates, in combination with the availability of novel buprenorphine-inspired
compounds, sets the breakthrough stage for the identification of an effective medication for opioid-induced
adverse effects and sheds light on future clinical interventions and the treatment options for opioid use
disorder.

Public health relevance
PROJECT NARRATIVE Opioid misuse and abuse are a rapidly evolving public health crisis. The proposed research could result in the identification of an effective medication for opioid-induced adverse effects in nonhuman primate models. If proposed aims are achieved, this project will facilitate design of new treatment options which can ameliorate adverse consequences of using opioids afflicting a large population worldwide.